HERITABLE, EPIGENETIC EFFECTS OF PATERNAL ALCOHOL USE ON FASD PHENOTYPES

Project Summary & Abstract
In the US, it is estimated that at least 1% of children suffer from alcohol-related growth and neurocognitive
defects associated with fetal alcohol spectrum disorders (FASDs). One of the major confounding elements in the
study of this disorder is the enormous variation observed in both incidence and severity. The observed variance
in FASD phenotypes indicates that multiple factors beyond the incidence of maternal drinking play a significant
role in the development of this condition. Over the past 40 years, clinical studies have reported that 75% of
FASD children have biological fathers who were either heavy drinkers or chronic alcoholics. However, the role
of preconception male alcohol consumption in the development of FASD birth defects remains unexplored,
largely due to the misconception that sperm do not transmit heritable information beyond the genetic code.
Using a well-established mouse model, preconception male alcohol exposure has been associated with both
prenatal and postnatal growth restriction, abnormalities in placental growth and sex-specific alterations in the
long-term metabolic health of the offspring. The defects identified in these animal studies are similar to those
described in long-term clinical studies of FASD children and reveal that paternal drug use is a significant
modifier of offspring health. However, the molecular mechanisms by which paternal exposures prior to
conception impact offspring development remain poorly defined. Further, the ability of paternal alcohol use to
interact with gestational alcohol exposures and exacerbate the development FASDs has never been tested. This
proposal responds to `PA-18-507 - Effects of In Utero Alcohol Exposure on Adult Health and Disease' and will
define the basic fundamental mechanisms by which male preconception exposure to alcohol impacts the
developmental program of the fetus and contributes to the incidence of FASD birth defects. Identifying a link
between male alcohol use and a disorder that, until now, has been almost exclusively associated with the
decisions of the birthmother, will hopefully prompt a shift of epidemiological perspectives that will more fully
consider the lifestyle choices of the birthfather in the development of alcohol-related growth and neurocognitive
defects.

Public health relevance
Project Narrative In the United States, seventy percent of all males report the consumption of alcohol, while forty percent drink at a binge level. While fetal alcohol spectrum disorder is undoubtedly linked to maternal alcohol consumption, emerging evidence suggests a significant male contribution to this debilitating condition. This proposal responds to `PA-18-507 - Effects of In Utero Alcohol Exposure on Adult Health and Disease' and will define the basic fundamental mechanisms by which male preconception exposure to alcohol impacts the developmental program of the fetus and contributes to the incidence of birth defects.